SCIP, HOP & JUMP: Summer Clinical Immersion Program, Hands on Prototyping, and Jump-starting Design Projects towards Translation

PROJECT SUMMARY/ABSTRACT
Union College's ABET accredited Biomedical Engineering (BME) Program places an emphasis on close
faculty-student interaction and hands-on learning in educating undergraduate students, culminating in an
immersive Senior year Capstone Design experience. As the next generation of medical device designers, BME
students need to meet the challenges of innovating and developing solutions to address shortcomings in
current medical device technology while navigating a very complex pathway to commercialization of a new
medical device. At the cornerstone of this proposal is an established collaboration with the Albany Medical
College's Biomedical Acceleration and Commercialization Center (AMC/BACC), which enables high-impact
learning in a clinical setting. In addition, Union is further enriching its BME curriculum with an expanded, two-
term (20-week) Capstone Design Course Sequence. With these elements in place, the framework exists to
support the development of an enhanced Capstone Design experience with three specific aims: (1) Create a
sustainable Summer Clinical Immersion Program (SCIP); (2) Offer enhanced hands-on prototyping (HOP)
opportunities for solution iteration in tandem with close faculty supervision and external mentorship throughout
the Capstone Design Course Sequence; and (3) Jump-start (JUMP) design projects towards translation. The
proposed educational activities will enable students to begin their Capstone Design experience earlier, during
the Spring term of their Junior year, and extend the work on their designs through the Spring term of their
Senior year. This full year experience coupled with mentorship by program faculty, physicians, industry
experts, and entrepreneurs will significantly increase students' ability to traverse the path from initial problem
identification to prototype solution development. The proposed enhanced Capstone Design experience will
also give students more time for in-depth exploration of issues related to biomedical device translation before
they graduate. One measure of success will be the commercialization potential of the solutions that have been
prototyped by the student teams. AMC/BACC's technology transfer process will be employed to assess
patentability of designs, and the expertise at AMC/BACC will help determine the viability of the team forming a
company to advance their solution towards translation. A second measure of success will be obtained by
surveying graduates to determine what career paths they have chosen, demonstrating that achievement of the
three aims better prepares students and opens up new opportunities for them to succeed in a variety of career
paths related to the development of biomedical technology. Assessment data will be used to inform new
iterations of the Capstone Design experience elements, including course materials, instruction methods,
mentors, topic areas, facilities, and equipment for prototyping that will improve students' success in developing
solutions to medical problems and finding productive careers in biomedical device development.

Public health relevance
PROJECT NARRATIVE Increasingly, students in four-year undergraduate Biomedical Engineering programs are expected to gain advanced knowledge and enhanced training for workforce preparedness by engaging in learning experiences outside fundamental engineering content taught in the classroom, such as: (1) immersion and observation in a clinical setting, and (2) understanding the process and pathways of translating biomedical innovation towards commercialization for clinical and patient use. This project seeks to design and deliver valuable hands-on, learner-centered content to Union College's Biomedical Engineering majors through an intensive Summer Clinical Immersion Program at Albany Medical College where students will identify unmet needs in the clinic, feeding directly into a sustained educational experience through an expanded Capstone Design Course Sequence that encourages exploration of the translation pathway while also providing the expertise, resources, and mentoring necessary for students to jump-start their solutions towards commercialization. Union's proposed Summer Clinical Immersion Program and enhanced Capstone Design Course Sequence will not only create solutions to meet current medical needs but will also better prepare undergraduates to contribute immediately to established or startup biomedical device companies, bolster students' understanding and expertise in biomedical device development, and empower them to confidently navigate the path from initial solution to final product.